Emotional Granularity and Interoceptive Accuracy: Affective Skills Linking Dimensions of Childhood Adversity with Adolescent Stress Vulnerability

PROJECT SUMMARY
Childhood adversity is common and increases risk for multiple forms of psychopathology emerging in
adolescence. Heightened sensitivity to stress is one pathway through which childhood adversity may increase
mental health risk, such that stressful life events are more likely to lead to psychopathology in those who have
experienced childhood adversity. However, understanding of the impacts of childhood adversity has been
limited by conceptualization of adversity as a single construct and a focus on mechanisms, such as the
hypothalamic-pituitary-adrenal axis, that are challenging to intervene upon. Considerable evidence supports
the assertion that the impacts of adverse experiences on neural, cognitive, and affective functioning can be
categorized along dimensions of deprivation and threat. The proposed project investigates how deprivation and
threat may compromise two key affective skills through which youth reduce uncertainty to navigate stressors in
their daily lives: interoception and emotional granularity. Interoception is the brain’s modeling of the state of the
body. Youth exposed to threat may have lower interoceptive accuracy following stressors, increasing mental
health vulnerability to stress. Children who experience high levels of deprivation are likely not exposed to
experiences that support them in developing well differentiated emotion concepts and may consequently have
low emotional granularity, increasing their vulnerability to stress. The target sample is 200 adolescents (100
female) aged 11-20 years sampled to ensure high variability in exposure to deprivation and threat. Participants
will complete a baseline visit, engage in Ecological Momentary Assessment (EMA) over 14 days, and complete
an online 18-month follow-up assessment. Childhood adversity, emotional granularity, interoceptive accuracy,
stress, and psychopathology will be assessed through multimodal assessments including questionnaires,
structured interviews, behavioral tasks, psychophysiology, and EMA. Analyses will evaluate the association
between threat and interoceptive accuracy (Aim 1), the association between deprivation and emotional
granularity (Aim 2), the role interoceptive accuracy in mental health vulnerability to stress (Aim 3), and the role
of emotional granularity in mental health vulnerability to stress (Aim 4). Interoception and emotional granularity
are common targets for existing interventions. However, their role in the link between childhood adversity and
psychopathology remains under-identified. This research has the potential to establish important sources of
risk and resilience for youth exposed to adversity with clear applications to treatment and preclinical
interventions. Students will be integral to executing every aspect of this research plan, including task
development, recruitment, data collection, data processing, and data analysis. The execution of this research
will provide in-depth research experience to students from minoritized backgrounds that are underrepresented
in the biomedical workforce, launching them on a path toward careers in biomedical science and serving the
NIH’s strategic goal of diversifying the biomedical workforce.

Public health relevance
PROJECT NARRATIVE This project aims to evaluate the role of two key affective skills – emotional granularity and interoceptive accuracy – that support coping with stress and uncertainty in adolescence, their relation to childhood adversity, and their role in contributing to resilience or vulnerability to the mental health impacts of daily stressors. A better understanding of the sources of individual differences in emotional granularity and interoceptive accuracy will allow for improvement of existing effective interventions targeting these skills and application of those interventions to improve outcomes among youth exposed to childhood adversity.